Resolution of inflammation in healing myocardial infarcts.

ABSTRACT:
The proposed supplement will extend the studies of the parent grant to investigate fibroblast-
specific actions of Smad1, and Smad2/3 in aging hearts. Study across the lifespan is a major
priority of the NIH, and is particularly important in cardiovascular investigations, due to the high
prevalence of heart disease in the elderly. The parent proposal explores effects of Smad1 vs
Smad2/Smad3 signaling in reparative fibrosis. This supplement will extend these experiments in
older animals to test the hypothesis that age-associated perturbations of the balance between
fibroblast Smad1 and Smad2/3 signaling may be implicated in the pathogenesis of age-associated
fibrosis and diastolic dysfunction. The hypothesis will be tested in 2 specific aims:
Aim 1 will study the in vivo effects of fibroblast-specific Smad1, Smad2 and Smad3 signaling in
aging hearts. Fibroblast-specific KOs generated in the parent grant will be used to examine effects
of the Smads on age-associated fibrosis, remodeling and dysfunction..
Aim 2 will investigate the in vitro effects of Smad1 and Smad2/3 knockdown on senescent cardiac
fibroblast phenotype and function. siRNA KD and Cre-mediated Smad deletion approaches (used
in the parent grant) will be performed in cardiac fibroblasts harvested from young and old mice.
Functional assays examining fibroblast migration, proliferation and myofibroblast conversion will
be performed.

Public health relevance
NARRATIVE: The supplement will extend the experimental work proposed in the parent grant in older animals. The goal is to study how the imbalance between Smad1 and Smad2/3 signaling may be involved in the fibrotic changes of the heart associated with aging.